Administrative Core

CORE 1 SUMMARY
The overall goal of Administrative Core (Core 1) is to promote the effective integration and
management of the different projects and cores in this Program which consists of three research
Projects and four shared Cores built around the central research emphasis on SARS-CoV-2
infection and innate immunity. Core 1 will provide leadership, administrative coordination,
communication, financial management. Core 1 will also oversee quality control for enhancing
research productivity and fostering the development and maintenance of the interactive research
environment. Core 1 will provide a coordinated plan to allow the program members to
communicate, collaborate, share data, ideas, protocols, results, samples, infectious agents,
mouse models, organs, RNAseq data and reagents. It will manage and oversee the fiscal,
communications and compliance aspects of this P01. Core 1 will be responsible for the day-to-
day management of administrative and budgetary issues of the entire P01.